Understanding the connection between exposure to mercury, auto-immunity and tolerance in B cells.

ABSTRACT
Mercury (Hg) is a xenobiotic that is widespread in the environment. Mercury is also a potent immunomodulator
that has been implicated as a factor contributing to autoimmune disease in animal models and humans. A
recent epidemiological study has now convincingly shown that, in otherwise healthy individuals who were only
exposed to low levels of Hg through typical environmental sources, there is a correlation between blood Hg
levels and the appearance in the blood of antibodies to double-stranded DNA, an autoimmune biomarker. This
finding indicates that under the proper circumstances, exposure to environmental Hg promotes autoimmunity,
a precursor to autoimmune disease. Since the discovery of B cells, immunologists have appreciated that, in
light of the Clonal Selection Theory, during the normal course of B cell development, large numbers of
immature B cells must be generated that produce immunoglobulin that is reactive to many self-antigens (auto-
antibodies). However, in the course of normal development, the vast majority of immature auto-reactive B cells
are prevented from maturing by processes collectively known as tolerance. Autoimmune disease arises when
the mechanisms that promote tolerance are disrupted. For B cells, it is firmly established that tolerance
depends to a large extent on signals generated by the B cell receptor (BCR) in immature B cells. Our
preliminary and recently published studies have shown that Hg interferes with signal generation by the BCR in
immature B cells, through mechanisms that likely involve the tyrosine kinase Lyn, the tyrosine phosphatases
SHP-1 and CD45 and elements of the cytoskeleton. Our overall hypothesis is that environmental exposure to
Hg disrupts BCR signaling in Hg-exposed compared with non-exposed animals, resulting in the disruption of B
cell tolerance in exposed animals. This in turn should lead to the appearance of an excess of mature auto-
reactive B cells in Hg-exposed animals that have the potential to cause autoimmune disease. We propose to
test this hypothesis by generating anti-hen egg lysozyme (HEL)/hen egg lysozyme double transgenic mice
which are designed to be normally tolerant to HEL, and them exposing them or not to Hg, in order to break
HEL tolerance (Aim 1). We will expand on our preliminary data to further elucidate the molecular mechanisms
that enable Hg to interfere with BCR signaling. We will utilize mouse strains with different genetic
susceptibilities to Hg intoxication to directly investigate how Hg interferes with the function of the tyrosine
kinase Lyn and the tyrosine phosphatases SHP-1 and CD45 during BCR signaling under the influence of
different genetic backgrounds (Aim 2). We will use complementary proteomic and multicolor phosphoflow
cytometric approaches to determine how Hg interacts with elements of the cytoskeleton, so as to attenuate
BCR signaling (Aim 3).

Public health relevance
Project Narrative Previous studies suggest that exposure to environmental mercury leads to autoimmunity and potentially to autoimmune disease. We have found that mercury interferes with the function of an important group of proteins on the surface of B lymphocytes, the B cell receptor (BCR) complex. It is our hypothesis that exposure to environmental mercury leads to autoimmunity because mercury interferes with BCR signaling. Proper BCR signaling is known to be important to prevent autoimmunity and autoimmune disease. The experiments proposed in this application are designed to see if our hypothesis is correct, and to more fully understand just how mercury exerts this interference on a molecular level.